Clinical Research Facility

Description: (Applicant's Description) The Indiana University Cancer Center has a large clinical trials program, with approximately 180 trials open to patient enrollment at any given time. The staff of the Clinical Research Office (CRO) provides essential services that enable the clinical investigator to efficiently conduct trials. These services begin in the early stages of protocol development and continue throughout study implementation, publication, and long-term follow-up. This support is provided to investigators in both the Adult and Pediatric Oncology Programs by offices and Riley Hospital and the Indiana Cancer Pavilion. Close linkages are maintained with the Biostatistics Shared Facility to insure the smooth transfer of data. The CRO also supports the activities of the Cancer Center Scientific Review Committee (SRC). Support in this application is requested for the following functions of the CRO: training and supervision of research staff, quality assurance, maintenance of computerized databases to track protocols and patient data, and interaction and data transfer with the Biostatistics Facility.